BCCMA: Vascular Regeneration for PAD: Therapeutic Delivery of Angiogenic Stem Cells and mRNA-Based Gene Therapy

ABSTRACT: Rationale: We propose CLIMB (Cell Therapy Leveraging Innovations in BioMaterials and
Biomanufacturing) to leverage the complementary expertise of the investigators as a BLRD and CSRD
Collaborative Merit Review Award (BCCMA) by sharing knowledge, resources, and data to jump-start the next
generation therapeutic platform for improved vascular and muscle repair in small and large animal models of
chronic limb threatening ischemia (CLTI). The central hypothesis of this BCCMA that a comprehensive program
addressing macro- to micro-vascular and muscle deficits is needed to advance CLTI treatment and that by
sharing and synergizing our complementary expertise, resources, and results, the CLIMB team will be best
positioned to address the clinical goal of reducing higher level amputation in CLTI patients. We will develop this
comprehensive program by completing the following Specific Aims: (i) increase the quality of therapeutic cell
preparations by testing new cell types, and by improving their viability and angiogenic function using instructive
biomaterials as cell carriers; (ii) develop new delivery methods to deploy the cell and tissue constructs at the
target site; (iii) enable the rational design of new biomaterial-based vascular grafts; and (iv) develop new
imaging and microfluidic strategies to enable proper selection of therapeutic interventions for CLTI patients.
The objective of this specific project is to test the efficacy of a combinatorial strategy to enhance both
vascular and muscle regeneration. The first strategy consists of parallel-aligned nanofibrillar collagen scaffolds
for spatiotemporal delivery of chemically modified mRNA (mmRNA) encoding a potent muscle regeneration
factor. The second strategy consists of human induced pluripotent stem cell-derived ECs (iPSC-ECs) expanded
on mechanically tunable hydrogels to improve endothelial phenotype, expansion, and function yet inhibiting de-
differentiation during in vitro manufacturing. The global hypothesis is that delivery of both pro-myogenic and pro-
angiogenic therapies will maximize tissue repair in small and large animal models of hindlimb ischemia (HLI) as
an experimental model of CLTI. Specific Aim 1 will test the hypothesis that treatment of aligned nanofibrillar
collagen scaffolds with spatiotemporally controlled delivery of mmRNA encoding pro-myogenic insulin-like
growth factor-1 (IGF-1) will induce muscle regeneration in a mouse HLI model. Specific Aim 2 will test the
hypothesis that iPSC-ECs maintain more stable endothelial phenotype, higher angiogenic function, and greater
expansion potential in mechanically optimized substrates than on conventional tissue culture dishes. Specific
Aim 3 will test the hypothesis that a combinatorial approach involving iPSC-EC-seeded IGF-1-mmRNA releasing
scaffolds will maximize muscle and vascular regeneration in murine and porcine models of HLI. If successful,
these studies will advance the treatment outcomes for Veterans with CLTI.

Public health relevance
NARRATIVE: Peripheral artery disease is associated with obstructions to vessels that supply blood flow to the arms and legs, leading to limb ischemia and impairment of the skeletal muscles in the ischemic limb. Veterans are at high risk of developing severe cases known as chronic limb threatening ischemia (CLTI). The objective project is to test the efficacy of a dual strategy to enhance both vascular and muscle regeneration. The first part consists of parallel-aligned nanofibrillar collagen scaffolds for localized and transient delivery of chemically modified mRNA (mmRNA) encoding a potent muscle regeneration factor. The second strategy consists of human induced pluripotent stem cell-derived ECs (iPSC-ECs) expanded in mechanically tunable hydrogels to improve endothelial phenotype and function yet inhibiting de-differentiation during in vitro manufacturing. The global hypothesis is that delivery of both pro-myogenic and pro-angiogenic therapies will maximize tissue repair in small and large animal models of hindlimb ischemia as an experimental model of CLTI. .